Advisory Committees

The purpose of this Core is to provide funding for meetings of two advisory groups that provide scientific and administrative oversight to the Mouse Genome Database Program, an external Advisory Board and an internal (TJL) Advisory Committee.